Developmental Infrastructure Core

Objectives: The Developmental Core will play a prominent role in the revitalization of CSDA as it reorganizes in line with current budget realities. Though important to all CSDA Associates and Affiliates, the core will be instrumental in seeking to identify and incorporate promising young population researchers as they join the faculty.